Decoding mechanisms of early life inflammation

One in four children in the Western world develop atopic dermatitis (AD), a devastating
inflammatory skin disorder, often appearing as early as 8 weeks after birth. Existing therapies
targeting show limited efficacy in young children, highlighting the need for interventions tailored
to early life. Yet, how the early life immune system responds to allergens is poorly understood.
This research project aims to elucidate the innate and adaptive mechanisms governing neonatal
immune responses and investigate how the innate immune system detects and mediates sterile
inflammation during this critical developmental stage. We developed a novel mouse model of
allergen-induced neonatal sterile inflammation, to prove mechanisms controlling immunity in this
developmental window. In so doing, we uncovered heightened innate and adaptive immune
responses in neonates compared to adults. Preliminary findings show neonatal dendritic cells
(DCs) exhibit a unique "promiscuous" activation state, and Type 17 cells active directly in the skin,
suggesting heightened reactivity in neonatal skin. In this application we will study the cellular and
molecular mechanisms of heighted early-life immune system that underlie neonatal propensity for
inflammation. This knowledge will have profound implications for the development of targeted
therapeutics and preventive strategies against early-life sterile inflammation. Additionally, our
research will contribute to a fundamental understanding of the mechanisms of neonatal immunity,
with broad applications in early life immunization and anti-pathogen immunity.

Public health relevance
Our proposed studies aim to decipher the immune mechanisms responsible for early-life susceptibility to atopic inflammation. Using an innovative new mouse model and advanced techniques, such as mouse genetics and bio-orthogonal chemistry, the study aims to uncover critical regulatory mechanisms. The insights gained will have broad applications in targeted therapies, including preventive strategies for sterile inflammation, insights into anti-pathogen responses and advancements in immunization in early life.